A CCR5 Blocking Antibody as HIV Pre-exposure Prophylaxis

PROJECT SUMMARY With 36 million people currently living with HIV worldwide and no vaccine currently available, developing a pre- exposure prophylactic (PREP) HIV regimen that protects against sexual transmission remains a top global health priority. Recently, a CCR5 blocking monoclonal antibody, Leronlimab, has shown exceptional safety, tolerability, and anti-HIV activity in multiple clinical trials. Given that sexual transmission of HIV is almost exclusively mediated by CCR5-tropic variants, Leronlimab may be extremely effective as a PREP reagent. To test this hypothesis, we will test the ability of bi-weekly dosed Leronlimab to prevent mucosal acquisition of SHIV in macaques. In specific aim 1, we will administer Leronlimab and sham every two weeks and challenge macaques weekly with low dose SHIV intra-rectally. In specific aim 2, we will measure the CCR5 occupancy in blood and rectal tissues of treated animals. These studies will lay the foundation for testing Leronlimab clinically as PREP in individuals at high-risk of acquiring HIV.

Public health relevance
PROJECT NARRATIVE The development of a pre-exposure prophylactic reagent that potently inhibits transmitted HIV with minimal toxicity, lack of potential for drug-drug interactions, and infrequent dosing would greatly slow the HIV epidemic. Given that nearly all mucosally-transmitted HIV is CCR5 tropic, we will test the ability of a novel CCR5 blocking antibody to prevent mucosal transmission of HIV using the macaque model. Success of these studies would establish a new pre-exposure prophylactic weapon for the fight against HIV.